Effect of high fat diet on the circadian system and on circadian rhythms in energy intake and expenditure

Abstract
Obesity is an ongoing epidemic and a serious public health problem. Preventative and therapeutic interventions
have mostly focused on diet and physical activity, aimed to understand mechanism and improve efficacy. Notably,
there has been a long-term debate over whether macronutrient content in the diet, specifically a low fat vs. low
carbohydrate diet can help in management of body mass. Recent insights into the involvement of the circadian
system in energy balance control offer a new perspective to understand the relationship between macronutrient
intake and weight control. We and others have shown that disruption of the circadian system leads to adverse
metabolic effects, including changes in energy balance control mechanisms that can increase the risk for obesity.
Indeed, circadian disruption is a recognized critical risk factor for metabolic disorders, as also recognized by the
Nobel Prize Committee who awarded the 2017 Nobel Prize in Physiology or Medicine to three circadian pioneers.
Given the intimate reciprocal interactions between metabolism and the circadian clock, it has been proposed
that dietary macronutrient content may impact whole-body physiology in part through changes in the circadian
organization. Consistently, breakthrough animal experimental work has shown that high fat diet leads to
disrupted circadian rhythms, including blunted rhythms and lengthened circadian period (cycle length). These
findings are consistent with our Preliminary Data in humans, in which we found that higher percentage of 24-h
fat intake is associated with (i) a blunted endogenous circadian rhythm in hunger; (ii) a higher caloric intake in
the biological evening; (iii) lengthened endogenous circadian period; and (iv) a delayed endogenous circadian
phase. Taken together, these results provided strong premise for high fat diet-induced circadian disruption.
However, despite the growing realization of the importance of circadian organization and the influence of fat
intake on the circadian system, there is very limited experimental data in humans that has tested the effect of
high fat diet on the circadian clock or circadian control of metabolism. Therefore, in this proposal, we will address
these knowledge gaps by testing the following hypotheses: high fat diet, as compared to low fat diet results in
(Aim 1) blunting and delaying of endogenous circadian rhythms of the central clock and measures related to the
peripheral clocks; (Aim 2) blunting and delaying in daily and endogenous circadian rhythms in energy intake-
related measures; (Exploratory Aim 3) blunting and delaying in daily and endogenous circadian rhythms in
energy expenditure-related measures. These aims will be tested in a within-subject, randomized, crossover
design in healthy individuals undergoing two protocols. Each of both protocols has a short-term field-based
dietary intervention (2 weeks to avoid substantial weight change) followed by a 6-day highly controlled in-
laboratory visit. Understand the link between macronutrient intake and the circadian system will lay the
groundwork for evidence-based dietary intervention integrating timing in the prevention and treatment of obesity
and metabolic health.

Public health relevance
Narrative Breakthrough animal experimental evidence and preliminary human data suggest that high fat-dietary intake may disrupt circadian organization and that circadian disruption increases the risk for obesity. This project will determine whether a high-fat diet, vs. a low-fat diet, will alter the circadian system and thereby circadian rhythms in energy intake and expenditure in humans. This research will provide novel mechanistic insights into the link between macronutrient intake and the circadian system, and may help in the design of evidence-based dietary intervention incorporating “timing” to combat the obesity epidemic.